Pathogen-induced cellular senescence and blood-brain barrier dysfunction in Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease (AD) remains a devastating illness for which there are limited prevention and treatment options.
Vascular endothelial dysfunction as manifested in the loss of the blood brain barrier (BBB) integrity can precede
symptomatic cognitive decline in AD patients and thus suggests that vascular pathology may be involved early on
in AD development and progression. Endothelial cells (ECs) play several critical roles such as tightly regulating the
transport of molecules across the BBB as well as the influx of immune cells which can induce inflammation and thus
promote AD. Recent data suggest that viral or bacterial infections can increase the incidence and progression of
Alzheimer’s disease. There is also growing evidence that premature cellular senescence impairs blood brain barrier
function and promotes neuroinflammation. However, the mechanistic roles of cellular senescence and blood-brain
barrier dysfunction in mediating pathogen-induced AD progression remain unclear. Our preliminary data suggests
that viral and bacterial pathogens can initiate blood brain barrier dysfunction by direct activation of inflammatory
signaling as well as by increased expression of endogenous retroviruses which in turn initiate a cascade of
hyperinflammation. We have developed a novel computational algorithm SenePy to analyze cellular senescence in
single cell transcriptomic data and found significant increases in cellular senescence associated with expression of
endogenous retroviruses in experimental mouse models of Alzheimer’s disease as well as human brains with
Alzheimer’s disease We have thus formulated the overall hypothesis that pathogen-induced cellular
senescence and blood -brain barrier dysfunction mediate Alzheimer’s disease. The proposed experiments will
leverage experimental mouse models of Alzheimer’s disease, molecular characterization of endogenous retrovirus
RNA sensing as well as human iPSC models.

Public health relevance
NARRATIVE Alzheimer’s disease is devastating for patients and their families because there are currently no drugs which can prevent the disease or cure the disease. Recent studies suggest that some infections by bacteria or viruses may contribute to the development or worsening of Alzheimer’s disease, possibly by causing leaky blood vessels and inflammation. We will perform scientific experiments to understand how bacteria and viruses can make Alzheimer’s disease worse with the hope to find molecules that could be targeted in new treatments.